Mechanisms of Chromosome Fragile Site Formation in the Human Genome

PROJECT SUMMARY/ABSTRACT
Common fragile sites (CFSs) are recurrent “wounds” in every person's genome that predispose
the chromosomes to DNA double strand breaks (DSBs) and rearrangements. Known features
associated with CFSs include late replication timing, which is further enhanced upon replication
stress, and large transcribed genes, which may cause replication-transcription conflict. CFS
formation/breakage underlies a wide variety of human diseases, including cancer and neurological
disorders. We recently mapped replication stress-induced DNA DSBs in a normal human
lymphoblastoid cell line, using Break-seq, a powerful NextGen-sequencing based technique
developed in my laboratory. DSBs, with or without replication stress, are associated with late
replication timing. However, these DSBs were not enriched inside large transcribing genes, nor are
they enriched inside cytologially defined CFS core sequences. We hypothesize that the differences
between Break-seq signals and CFS core sequences are attributable to the inherent differences
between technological platforms as each is biased toward a partial feature of the human CFS, with
Break-seq detecting the DSBs whereas the cytological methods detecting ssDNA gaps. The main
objective of our proposal is to directly test this hypothesis by creating an upgraded sequencing
technology, Fragile Site (FS)-seq, to simultaneously map ssDNA gaps and DSBs (Aim 1). Moreover,
preliminary evidence suggests that the ssDNA inside the CFS core sequences is a consequence of
“rogue” DNA initiation events upon high levels of DNA replication stress. Therefore, we will test if
alterations in replication timing gives rise to ssDNA at the CFS core regions (Aim 2). The proposed
project will bridge the gap in our current understanding of the mechanisms of CFS formation and
genome instability.

Public health relevance
PROJECT NARRATIVE Our proposed project centers on understanding how chromosomes undergo breakage during replication stressful conditions in the normal human genomes. We propose to map high resolution chromosome fragile sites in the normal human genome with a newly upgraded technology named Fragile Site(FS)-Seq to facilitate discoveries of underlying causal factors for genome instability.